Investigations to Assess the Role of Glucagon Signaling in Healthspan and Aging

Calorie restriction increases liver 5’AMP kinase (AMPK) activity. Like the glucagon receptor, AMPK is
essential for calorie restriction to extend lifespan and healthspan. Because AMPK is downstream of glucagon
receptor signaling it is possible that glucagon receptor activated AMPK is necessary for calorie restriction to
improve healthspan We propose that glucagon receptor signaling at the liver, which increases with both calorie
restriction and obesity, slows aging dependent upon glucagon receptor stimulated AMPK activity. The proposed
study will extend our findings from the parent grant to assess the ability to rescue the impaired healthspan in
glucagon receptor null mice by inducing hepatocyte expression of a constitutively active AMPK.

Public health relevance
Project Narrative The accelerated aging in type 2 diabetes mellitus (T2DM) and the enhanced longevity resulting from calorie restriction is largely attributed to the associated changes in insulin signaling, overlooking the potential role for glucagon signaling in aging. Given that many prominent diabetes treatments target glucagon or glucagon signaling pathways, it is essential to understand the role of glucagon in aging. The work proposed in this grant will close a significant gap in our understanding of how glucagon alters aging, while allowing us to assess the potential risks associated with inhibition of glucagon signaling.